Establishing Mechanisms of LOX-1-Dependent Immune Regulation During Pneumonia

Abstract
Pneumonia is the leading cause of infection-related deaths worldwide, a fact that is set to rise exponentially
with the SARS-CoV2 pandemic. Recovery from pneumonia requires both clearance of the pathogen and
resolution of infection, the latter of which is critical to resume normal lung function. While both processes are
important to host health, there is vastly less known about the mechanisms that regulate resistance to and
resolution of tissue injury during pneumonia, representing a large knowledge gap in our understanding of the
biology of the lung and its repair processes. Here, we propose that lectin-like oxidized low-density lipoprotein
receptor-1 (LOX-1) modulates acute pulmonary inflammation in way that promotes resolution through
reprogramming of leukocyte response. LOX-1 is a class E scavenger receptor, primarily known for its role in
promoting vascular inflammation during atherosclerosis. In direct contrast, our data suggests that LOX-1 has a
unique function in the lung, where it prevents edematous lung injury and inflammation, independent of bacterial
clearance in murine models of Escherichia coli and Streptococcus pneumoniae pneumonia. Moreover, LOX-1
and its major ligand oxidized low-density lipoprotein (oxLDL) are elevated in patients with ARDS as a result of
a confirmed diagnosis of pneumonia. Analysis of the cellular expression of LOX-1 in the lung revealed that
alveolar macrophages and recruited (airspace) neutrophils are uniquely enriched for LOX-1 expression.
Hematopoietic cells are also likely sources of LOX-1-dependent protection, as LOX-1-/- (WT recipient) chimeras
are significantly more protected from injury than WT (LOX-1-/- recipient) chimeras during pneumonia.
Assessment of the specific effects of LOX-1 inhibition on alveolar macrophages demonstrated that with
inhibition macrophages are skewed towards inflammation and exhibit metabolic changes associated with
increased glycolysis and lower fatty acid oxidation consistent with inflammatory macrophages. Moreover, we
discovered that recruited neutrophils differ in their expression of LOX-1, where about half of neutrophils are
positive during infection. Curiously, we also found phenotypic differences associated with LOX-1+ neutrophils
that suggest increased cholesterol metabolism, which may uniquely promote tissue resolution. Taken together,
leukocytes are an important source of LOX-1 and are likely responsible for LOX-1-dependent protection during
pneumonia. However, whether and how LOX-1 elicits its protective effects on leukocytes is not known. Thus,
we propose a central hypothesis that LOX-1 signaling evokes tissue-protective mechanisms in leukocytes
(K99), that are associated with metabolic changes consistent with reduced inflammation and increased tissue
recovery (R00). Results from our investigations will be the first to elucidate how LOX-1 is regulated at the
transcriptional and metabolic level in the unique microenvironment of the lung, where it likely facilitates
recovery from pneumonia and lung homeostasis.

Public health relevance
PROJECT NARRATIVE Pneumonia is the leading cause of infection-related deaths worldwide, necessitating a greater understanding of the mechanisms that regulate immune defense and tissue recovery in the lung post-infection. Lectin-like oxidized low-density receptor-1 (LOX-1) is a C-type lectin scavenger receptor that has a unique function in the lung, whereby it is protective against edematous lung injury and inflammation through alterations in leukocyte response that suggests a more pro-resolving phenotype. Whether and how LOX-1 promotes resolution of infection in the lung via resident and recruited leukocytes is not known and is the subject of the proposed studies, where effects of LOX-1 signaling will be investigated at the transcriptional (K99), metabolic (R00) and phenotypic level (K99/R00).